Studies on Viral Enhancer for Latency-Lytic Switch

Abstract
Kaposi’s sarcoma-associated herpesvirus (KSHV), also known as Human Herpesvirus 8 (HHV-8), is the etiologic
agent of three AIDS-associated malignancies: Kaposi sarcoma (KS), a plasmablastic variant of multicentric
Castleman disease (MCD), and primary effusion lymphoma (PEL). Although their incidence in HIV+ patients has
decreased since the introduction of antiretroviral therapy, KS remains the most common HIV-associated
malignancy. Concerningly, nearly one-third of patients who develop KS have well-controlled HIV infection, and
it is estimated that the incidence of KS may increase as the life expectancy of HIV+ patients increases. Although
less common than KS, MCD and PEL do not have standardized treatments and both exhibit poor prognosis. A
current area of research focus is to better understand the KSHV gene regulation to identify new drug targets to
control KSHV replication and associated neoplasms.
Amounts of nuclear enzymes and transcriptional factors are limited in the cell nucleus and cannot support
all of cellular transcription at the same time, the nuclear architecture including chromatin structure must allow for
these molecules to be located at the proper time and place for coordinated gene expression to occur. Alterations
in this organization could thus lead to a variety of diseases, including cancer. The principles underlying this
process are still poorly understood. We previously revealed (i) a 3D KSHV genomic structural and (ii) identified
key cellular proteins that play essential roles in both establishing/maintaining latency and induction of lytic
replication. The 3D structure modeling and recruitment sites of these key enzymes suggested to us an important
role for evolutionally maintaining multiple copies of terminal repeat sequences in the function of concentrating
specific protein near KSHV inducible promoters. Accordingly, we hypothesize that having large copies of terminal
repeat sequence foster an increase in the local concentration of LANA, and the 3D KSHV genomic structure is
designed to allow locally-concentrated LANA complexes to regulate viral lytic gene promoters located in unique
region. We will focus on function of terminal repeat sequence in regulation of lytic gene promoters.

Public health relevance
Project Narrative Kaposi’s sarcoma-associated herpesvirus (KSHV) causes Kaposi’s sarcoma and certain B cell lymphomas. Following infection, KSHV typically remains in a latent state as an episomal genome, which forms characteristic LANA nuclear bodies in cell nucleus. Defining regulation of LANA condensates and significance of clustering LANA DNA binding sites at terminal repeats will deepen our understanding of the KSHV gene regulation, and may lead to more efficacious therapeutic approaches to inhibit KSHV replication and treat associated cancers.